Defining Research and Care in Diabetes in Pregnancy

PROJECT SUMMARY
The 17th biennial meeting of the Diabetes in Pregnancy Study Group of North America (DPSG-NA) will be held
on October 26-28, 2023 as a hybrid virtual and in-person meeting at the Physicians Conference Center at Inova
Fairfax Medical Campus in Falls Church, VA. This 3-day research meeting focuses on pregnant individuals living
with type 1, type 2, and gestational diabetes mellitus. Since its inception over 25 years ago, the DPSG-NA
meetings have been a vehicle for the dissemination of data, gathered through collaboration among basic,
translational, clinical, and public health researchers and practitioners both in the United States and abroad. The
meeting covers a broad range of issues related to diabetes in pregnancy. The focus of the meeting is to highlight
major, timely research areas to catalyze future discovery. The major goal of this meeting is, and has historically
been, to serve as a driving force for discussions and new collaborations that open novel areas of exploration into
prevention, treatment, and management approaches. These efforts are expected to reduce the burden of
diabetes disease and its consequences for pregnant individuals and their offspring. The 17h biennial meeting
has a strong emphasis on diversity, emphasizing the importance of social determinants of health and global
perspectives, including low-and-middle-income countries. The meeting goals will be achieved through oral
presentations, roundtable discussions, and debates that will bring together the world’s experts, young
investigators, students, and trainees who have a committed interest to diabetes in pregnancy. The program
includes 4 keynote addresses that each will be dedicated to a giant in the field of diabetes in pregnancy. The
first keynote will be given in memory of Oded Langer by Roberto Romero, MD, DMed, Sci. Dr. Romero will
speak on the prediction and prevention of obstetrical diseases. In addition, Cynthia Gyamfi-Bannerman, MD,
MS will give the Elizabeth Thom Memorial Lecture where Dr. Gyamfi-Bannerman will speak of Dr. Thom’s
contribution as the biostatistician of the MFMU network in changing clinical care in diabetes. Finally, Kevan
Herold, MD will speak in the Lois Jovanovic Memorial Lecture and will address strategies to reduce the diabetes
epidemic in the United States. Other speakers include established experts and young investigators, with about
20% of the meeting time allocated for speaker-conferee discussions. Young investigator presentations are an
important aspect of the meeting, and they are an effective tool to help bring a new generation of scientists into
our community and foster their maturation. Informal discussions among conferees are highlights of this unique
meeting that fosters a collaborative, multifaceted approach to improving the health and wellbeing of pregnant
women with diabetes and their offspring.

Public health relevance
PROJECT NARRATIVE The major goal of 17th Biennial Meeting of the Diabetes in Pregnancy Study Group North America (DPSG-NA) “Defining Research and Care in Diabetes in Pregnancy” to be held from October 26-28, 2023 as both virtual and in person formats at the Physicians Conference Center at Inova Fairfax Medical Campus is to serve as a forum for discussions about cutting-edge research aimed to improve the prevention, management and treatment of diabetes in pregnancy. This meeting brings together national and international experts, practitioners, nurses, diabetes educators, junior faculty, fellows and students to participate in formal presentations and informal discussions. This meeting has a long history of addressing innovative and cutting-edge topics and the 17th biennial meeting has a strong emphasis on diversity, including emphasizing the importance of social determinants of health and global perspectives, in particular from low-and-middle-income countries.